Multiplex Imaging of Signaling Pathways in Cell Motility

Abstract
Advancements in cell biological technologies have enabled molecular processes to be interrogated in real time,
within living cells, at submicron-level spatial and second-level temporal resolution. Our lab has developed new
Förster resonance energy transfer (FRET)-based biosensor technologies utilizing monomeric, single-chain,
fluorescent proteins, offering good sensitivity, probe reversibility, and easy quantitation. We are exploring real-
world biological applications of our innovative FRET-based multiplex biosensor imaging technology, focusing
on the complex coordination of Rho GTPase signaling pathways to better understand their critical roles in
regulating cellular morphodynamics. We will continue developing our FRET-based, orthogonal biosensors for
direct multiplex imaging to study the coordination of GTPases, their regulators, and their downstream targets
during cell motility, adhesion, and migration. In the next 5 years of the program, we will first analyze the
coordination of signaling dynamics between Rap GTPases and cytoskeletal Rho GTPases during adhesion,
migration, and invasion of polarized cells. We will address newly identified intermediate signaling proteins that
connect and coordinate these two GTPase classes during cellular morphodynamic control in both normal and
diseased states. We will next target the spatial and temporal coordination of mDia1 and mDia2 formins,
immediate downstream effector targets of Rho GTPase that regulate the local availability of activated, non–
receptor tyrosine kinases, including Src, during cell motility and invasion. Interestingly, the differential,
upstream selectivity of Rho GTPase paralogs and isoforms may play important roles in coordinating the
activities of these two formin isoforms during cell migration and invasion, which we will address. We are also
exploring the control of cell polarity, macropinocytosis, and phagocytosis through the coordinated activation of
RhoG–Rac1 or RhoG–RhoA pathways. We are able to multiplex our new RhoG biosensor with Rac1 or RhoA
biosensors to directly address the upstream regulator-initiated pathways of RhoG that coordinate Rac1- and
RhoA-mediated cytoskeletal reorganization, driving physiologically important cellular functions. We are also
exploring the signal coordination centered around vesicular RhoB GTPase, which interfaces with the
cytoskeletal Rac1 and RhoA GTPase pathways and with vesicular trafficking through the Rab GTPase
pathway. We will explore next-generation, FRET-based multiplexed approaches using fluorescence lifetime
microscopy imaging to analyze FRET-based biosensors in living cells. This approach represents a long-term
exploratory goal, and we will initiate our work by extending the utility of multiplexed FRET-based biosensors in
living cells, exceeding the current limitation of two simultaneous biosensors in a single living cell. Our proposed
works and the research trajectory will dissect the coordination of Rho GTPases and associated pathways
governing cell adhesion, motility, and invasion by developing new biosensors, designing new imaging
approaches, and extending the biological applications of FRET-based biosensors in direct multiplex imaging to
monitor perturbations in signaling networks.

Public health relevance
Project Narrative Our research focuses on developing novel fluorescence microscopy imaging tools and techniques for observing enzymatic activities within living cells during movement, attachment, and invasion. By comparing the behaviors of healthy and diseased cells, such as normal, immune and tumor cells, we aim to deepen our understanding of the signaling proteins that mediate cell migration and invasion mechanisms. We are designing novel molecular tools that can simultaneously monitor multiple protein enzymatic activities in living cells, shedding light on how these activities are coordinated to regulate cell dynamics and functions.